Regulation of membrane trafficking by Coronins

ABSTRACT
The long-term goal of the parent grant (1R01GM138448-01A1) is to get a better understanding
of how the extensive family of the Coronins transduces cellular signaling cues into actin network
remodeling to support cell migration, intracellular transport and cytokinesis. Coronins are bona
fide actin-binding proteins, however they do not directly alter actin filament dynamics. Instead,
they function as signaling scaffolds that recruit a host of other actin-remodeling and actin-
regulatory proteins that work in concert to alter actin network architecture and/or dynamics. Most
of our understanding of the Coronins stems from studies on the structurally and functionally
related short Coronins (Coro1-6), but next to nothing is known about the long or tandem Coronins
(Pod-1, Coro7). Leveraging the expertise of the lab in single molecule TIRF microscopy, we are
investigating how Coro7 regulates actin filament dynamics, directly as well as indirectly through
interaction with actin-regulatory proteins, including the other Coronins. Additionally, we have
performed an in-depth proteomic analysis to build the first Coro7 interactome and developed
several Coro7 CRISPR knockout cell lines. Combined with our insights gained from the
biophysical and biochemical characterization of Coro7, we will use these tools to determine how
Coro7 mechanistically regulates cell migration and intracellular trafficking, and by extension tumor
cell metastasis and invasion.

Public health relevance
PROJECT NARRATIVE The subfamily of the tandem Coronins forms a structurally unique class among the extensive family of the Coronins, however to date their actin-regulatory functions remain completely unknown. Using a combination of single molecule techniques, protein crystallography, and cell biology, we will investigate how the mammalian tandem Coronin, Coro7, structurally and mechanistically inhibits Arp2/3-mediated nucleation induced by nucleation promoting factors (N-WASP, WHAMM, and JMY), and other Arp2/3 regulators, including GMF, and SPIN90. In addition, we will elucidate how these actin-regulatory activities of Coro7 work in concert with Arp2/3 and its various interactors in intracellular membrane transport and autophagy. Altogether, this proposal will shed light on the enigmatic actin- regulatory functions of the class of the tandem Coronins in vitro, and in cells.